Diabetes & Women's Health Study: long term health implications of GDM

The Diabetes & Womens Health Study, based on an innovative hybrid design combining new prospective data collection with historical data, aims to understand pathways and determinants underlying the progression from gestational diabetes (GDM) to type 2 diabetes (T2DM) and complications such as cardiovascular diseases.

GDM is a common pregnancy complication. Women who develop impaired glucose tolerance and/or GDM in pregnancy are at substantially increased risk for T2DM in the years following pregnancy. Determinants underlying the transition from GDM to T2DM are not well studied and available studies are limited. There is limited information about the genetic and environmental factors that impact this transition in particular. Further, there is limited research aimed at following women with GDM long term through later adulthood for the development of T2DM and co-morbidities. These critical data gaps serve as the impetus for this study with the overall goal of investigating genetic factors and their interactions with risk factors amenable to clinical or public health intervention in relation to the transition of GDM to T2DM. A secondary goal of the study is to evaluate feasibility of investigating the long-term impact of GDM and other intrauterine factors on the health and wellbeing of offspring.

Data collection for this study builds upon two large existing cohorts: the Nurses' Health Study II (NHS-II) and the Danish National Birth Cohort (DNBC). The overall design of the study was published in 2014 (Zhang et al. Acta Obstetricia et Gynecologica Scandinavica). The DWH Study data collection was completed in 2016 and initial work focused on long-term comorbidities of GDM and potentially modifiable pathways. We recently published the cohort profile for the study which describes the study, the main findings, and opportunities for collaboration (Zhang BMJ Open 2019).

Using data from the two independent populations within the DWH Study, the NHS-II and DNBC, we identified eight novel GDM SNPs (Ding et al. Diabetologia, 2018). These findings offer the potential to improve our understanding of the etiology of GDM, and particularly of biological mechanisms related to beta cell function. Further we have identified that in independent populations of white women with a history of GDM within the DWH study, a higher genetic risk score (GRS) for type 2 diabetes was significantly associated with a higher risk of T2D. The findings were largely consistent between the two populations. We also found suggestive evidence that the GRS association may be stronger among women with poorer dietary quality after the index pregnancy than among women with a better dietary quality.

Using data from the DWH Study, we have demonstrated that GDM may be an early indicator of subsequent subclinical renal dysfunction (Rawal et al. Diabetes Care, 2018). Our findings suggest that in women with a history of GDM, deterioration of renal function may potentially precede the development of overt diabetes, although clinically relevant outcomes such as elevated UACR may manifest only after progression to diabetes. We have also shown that women with GDM during pregnancy were at an increased risk for fatty liver 9-16 years postpartum (Donnelly 2019 Journal of Diabetes). GDM may serve as another risk indicator for early identification and prevention of liver fat accumulation.

We also examined for potentially modifiable risk-factors associated with long-term health among women with a history of GDM. In Danish women with a history of GDM, our findings suggest a positive association between a longer duration of lactation and higher levels of thyroid hormone 916 years postpartum, even among women with a single lifetime pregnancy (Panuganti et al. Nutrients, 2018). We identified lactation as a novel potential modifiable factor for thyroid function, and with replication, these findings may add thyroid function to the wide-array of long-term cardiometabolic outcomes associated with increased lactation duration. In addition, we demonstrated that prolonged lactation duration was related to lower risk of type 2 diabetes (Ley et al. Diabetes Care, 2020) and improved cardio-metabolic risk profiles (Ley et al. BMJ Diabetes Research and Care, 2020) among women with a history of GDM. We also investigated modifiable dietary factors among women with GDM. We found that that among Danish women with a history of GDM, a population at high risk for cardiometabolic diseases, artificially sweetened beverage intake was not associated with either improvements or determents in cardiometabolic complications (Hinkle et al. American Journal of Clinical Nutrition 2019). Although high-risk individuals are recommended to consume artificially sweetened beverage instead of sugar sweetened beverages as a means of reducing sugar intake and risk for cardio-metabolic diseases, we did not observe significant improvements or determinants in cardiometabolic health with higher artificially sweetened beverage intake in this population. in addition, we observed moderate alcohol consumption among U.S. women with a history of GDM was related to lower risk of type 2 diabetes (Hinkle et al. JAMA Network Open, 2021). Taken all these together, findings from the study suggested that the greater long-term risk for type 2 diabetes and comorbidity may be mitigated through modification of diet, lifestyle and behavior factors. The study team is in the process of examining the joint impacts of modifiable risk factors and genetic factors on long-term risk of type 2 diabetes and cardiovascular diseases among women following pregnancies complicated by GDM.